Collateral Consequences of Parents Incarcerations for Their Adolescent Children: A Prospective Longitudinal Study

PROJECT SUMMARY/ABSTRACT
More than 2.2 million people—disproportionately racial/ethnic minorities—are incarcerated in the U.S.
More than half of males and nearly 2/3 of females in prison have children. Racial/ethnic disparities prevail: 1
in 9 African American children and 1 in 28 Hispanic children have a parent in prison compared with 1 in 56
non-Hispanic white children. Incarceration, whether or not it occurs during the child's lifetime, may disrupt
families, alienate loved ones, and limit opportunities for employment, public housing, college admission, public
aid, and some occupations, leading to poverty and residential instability. Incarceration during the child's
lifetime may have direct consequences for the child: a new caregiver, moving homes, changing schools, or
placement in foster care. Despite the importance of data addressing these health inequities, no comprehensive
study has examined the consequences of parents' incarceration on their children. Prior studies, for example,
assessed parents' incarceration only globally (e.g., “yes/no,”); could not analyze the frequency and duration of
incarceration; conflated jail (pretrial and sentences <1 year) and prison (convicted felons, >1 year), and did not
examine collateral consequences. We will leverage data already collected in the Northwestern Juvenile Project
(NJP) to conduct the first comprehensive prospective study of the collateral consequences of parents'
incarcerations on their adolescent children. Begun in the mid-1990s, the NJP is a large-scale longitudinal
study of mental health needs and outcomes of youth after detention. Many of our participants (G1), now
median age 36, have children of their own, with whom we have maintained contact since 2002. We will study
466 families with children (G2) ages 10 to 17 years, a critical developmental period for problem behaviors. We
will (1) use prospective longitudinal data from the NJP (up to 14 clinical interviews with parents and official
records); (2) conduct new interviews with parents (n = 466) and an additional caregiver (n = 284) to ascertain
collateral consequences of incarcerations and child outcomes; (3) interview the 466 children to ascertain their
psychosocial functioning and experiences; and (4) conduct qualitative interviews (n = 48 children) to assess
their experiences of their parents' incarceration. The proposed study has 3 aims: (1) To examine the
relationship between parents' incarceration and their child's psychosocial outcomes in 4 areas: mental health,
substance abuse, antisocial (delinquent) behaviors, and education; (2) To identify how the collateral
consequences of incarceration mediate the associations found in Aim 1; and (3) To predict resilience,
identifying variables that mitigate consequences of parents' incarceration on child outcomes; we will focus
especially on malleable aspects of social environments. The proposed study responds to (1) Healthy People
2030, which promotes health equity and elimination of health disparities; (2) the Strategic Plan of NIMHD to
reduce health disparities; (3) the Strategic Plans of NIDA and NIAAA to address the causes and consequences
of drug and alcohol abuse; and, (4) NICHD's mission for all children to lead healthy, productive lives.

Public health relevance
PROJECT NARRATIVE More than 2.2 million people—disproportionately racial/ethnic minorities—are incarcerated in the U.S. Many of them have children, and racial/ethnic disparities prevail. We will leverage data already collected in the Northwestern Juvenile Project to conduct the first comprehensive prospective study of the collateral consequences of parents' incarceration on their adolescent children.